Visible Light Photocatalysis

PROJECT SUMMARY/ABSTRACT
Photochemical synthesis represents an exciting frontier for drug discovery and for biomedical research. The
ability of small, structurally complex organic molecules to interact with biomolecules and perturb their
behavior is at the heart of modern molecular medicine and chemical biology. The discovery of new drugs
and biological probes with new properties, therefore, relies critically upon the synthesis of new molecules
with unprecedented structures. Photochemistry has long been an underdeveloped technique in chemical
synthesis, in part because the irradiation of organic molecules with light results in the generation of highly
reactive, high-energy species that can react indiscriminately and unproductively.
We are investigating the ways in which addition of various reagents to photochemical reactions can control
these photogenerated intermediates in diverse ways. In this proposal, we describe two Specific Aims to
study how these reagents can result in powerful new bond forming methods.
Aim 1. We are exploring the ability of chiral catalysts to control the stereochemistry of photochemical
reactions.
Aim 2. We are exploring the ability of copper oxidants to enable the installation of functional groups onto
simple unfunctionalized organic scaffolds.
These methods enable chemical transformations that cannot otherwise be accomplished using
conventional, non-photochemical technologies. Thus, we expect that the results of our research will have
significant impacts both in fundamental academic chemical research and on the ability of biomedical
scientists to synthesize and discover the next generation of life-saving drugs.

Public health relevance
PROJECT NARRATIVE The discovery of new, life-saving drugs requires chemists to be able to synthesize new molecular structures. The research described in this proposal will use light to produce highly energetic reactive intermediates and then utilize various strategies to control their subsequent reactions. We expect the impacts of this research to have both fundamental scientific impacts and practical enabling impacts in modern drug discovery.